Analysis of a missense SNP in the aryl hydrocarbon receptor repressor gene that may disproportionately increase lung cancer risk in Black Americans

The parent grant studies a single nucleotide polymorphism (SNP) in the aryl hydrocarbon receptor repressor
(AHRR) gene that may influence the lung cancer risk of Black/African American (B/AA) subjects. AHRR is a
negative regulator of detoxification responses involved in the metabolism and elimination of tobacco smoke
carcinogens. B/AA men have the highest rate of lung cancer death compared to all other groups, with a 12%
higher lung cancer incidence rate and a 15% higher lung cancer death rate than White/European (W/E) men.
Elevated AHRR expression has been implicated in lung cancer risk; thus, a SNP that improves AHRR function
would likely increase lung cancer risk. We have identified a missense SNP, rs35008248, in AHRR exon 4 that,
while rare in W/E subjects, is present one third of B/AA subjects. The SNP was not included in most previously
used arrays. Preliminary data from GWAS explorer suggests an association with smoking in B/AA males
(p=3.87E-3) and with smoking-related cancers in B/AA subjects (p=0.04927). B/AA individuals comprise only a
small fraction of the subjects (<4%); power to determine the role of SNPs in this group has been limited. AHRR
is a negative regulator of the aryl hydrocarbon receptor (AHR). Upon tobacco smoke exposure, AHR binds to
polycyclic aromatic hydrocarbons, dimerizes with ARNT and the dimer binds to xenobiotic response elements
(XREs), switching on detoxification genes. In a negative regulatory loop, AHR/ARNT turns on AHRR, which also
binds to ARNT, competing with AHR/ARNT for XRE sites, dampening the detoxification response. The reference
allele of rs35008248 (T) encodes a leucine at position 114, while the alternate allele (C) encodes a turn-inducing
proline. Combined annotation-dependent depletion (CADD) suggests the SNP might affect AHRR function. In
the co-crystal structure of the AHRR/ARNT heterodimer, leucine 114 borders a loop entwining ARNT. We
hypothesize that a proline at position 114 constrains AHRR loop conformation, thereby stabilizing AHRR/ARNT
interaction, increasing the repressive effect of AHRR/ARNT heterodimers, interfering with the detoxification
response, and increasing lung cancer risk of B/AA smokers, 34% of whom carry the minor allele. Here we
will test for associations between genetic variation at AHRR and lung cancer outcomes using existing large-scale
genetic data in B/AA individuals (Aim 1), use CRISPR-based genome editing to engineer the minor allele into
the genome of our unique immortalized human alveolar epithelial cell lines and assess its effects on the response
to tobacco smoke in vitro (Aim 2), and test whether the amino acid at position 114 affects the kinetics of the
interaction between AHRR and ARNT (Aim 3).Together, the specific aims of this pilot project will provide insight
into the role of a potential functional SNP in AHRR that is common in B/AA subjects and that could help explain
their increased lung cancer risk. The Diversity Supplement will give Diego Velarde training in research in genetic
risk (Aim 1), CRISPR engineering/transcriptomics (Aim 2), and recombinant protein production/intermolecular
protein analysis (Aim 3). Most importantly, it will provide key training in cancer health disparities research.

Public health relevance
Black/African American men have the highest rate of lung cancer morbidity and mortality among all groups, with a 12% higher lung cancer incidence rate and a 15% higher lung cancer death rate than White/European men. We have identified a small genetic difference (called a single nucleotide polymorphism or “SNP”), that is rare in White/European individuals but is present in one third of Black/African American individuals. The SNP might affect the function of a protein involved in detoxification responses to tobacco smoke, and may thereby affect the lung cancer risk of smokers carrying this SNP. If true, this will be important information supporting lung cancer screening and tobacco cessation efforts in the Black/African American community.